Developmental Research Program

PROJECT SUMMARY/ABSTRACT – Developmental Research Program (DRP)
The goal of the UCLA SPORE in Brain Cancer Developmental Research Program (DRP) is to foster the
exploration of innovative research ideas through the funding of pilot developmental research projects in the
field of brain cancer. This program identifies new, innovative projects for funding that will constantly renew the
vigor of our Brain SPORE research portfolio and add to, augment, or replace current major research projects.
The DRP serves as a source of pilot funding and a timely mechanism to expand discovery within the SPORE.
Each year, 2 – 3 highly innovative proposals are selected for funding at $50,000 - $75,000 each. Prospective
developmental research projects are solicited through a request for applications (RFA) sent throughout the
UCLA main campus and affiliated institutions via institution-wide and region-wide channels through the UCLA
David Geffen School of Medicine (DGSOM), the Jonsson Comprehensive Cancer Center (JCCC), and the
Brain Research Institute (BRI). Faculty at all levels are encouraged to apply, both those beginning a research
career and established investigators who wish to re-direct their research into the field of brain cancer. This
provides a broad base of applicants and new ideas, and allows funding opportunities for investigators from a
variety of local and regional institutions. The DRP Selection Committee meets and selects the most
meritorious translational brain cancer research applications, with input from outside ad hoc reviewers as
necessary.
Funding is made primarily for new and innovative ideas/projects, but also to initiate intra- and inter-SPORE
collaborations. We anticipate funding of at least one underrepresented minority (URM) investigator's project
per year in the next funding cycle, and have identified a pipeline of potential URM candidates. The DRP will
receive supplemental funds from the UCLA David Geffen School of Medicine (DGSOM) Dean's Office and the
Jonsson Comprehensive Cancer Center (JCCC), which will allow for rapid and nimble funding of important new
initiatives within the scope of our overall SPORE research goals. The priority for funding will be those
initiatives/projects considered of highest scientific merit and with translational potential and relevance to the
overall mission of the UCLA Brain SPORE. Successful translational research projects may receive further
funding in the SPORE and replace unproductive funded major projects. The anticipated outcome of the DRP
is to enlarge the overall pool of brain cancer SPORE investigators at UCLA and to increase the diversity of our
Brain Cancer SPORE research portfolio.